Mali-Guinea Emerging Infectious Disease Research Training Program (Mali-Guinea EID-RTP)

ABSTRACT
The recent epidemics of Ebola in West Africa and the current COVID-19 pandemic highlight the need for a
critical mass of well-trained scientists and public health research professionals capable of studying and
responding appropriately, and a in timely manner, to emerging infectious diseases (EID) threats. This
competitive new application supports a new training program on EIDs in Mali and Guinea. This will build upon
and expand the scope of the existing FIC/NIH D43 training program based in the Department of Public Health
at the University of Sciences, Techniques and Technologies of Bamako (USTTB) and leverage on existing
NIAID collaborative research programs in the two countries. The existing D43 training program has a focus
on malaria and neglected tropical diseases (NTDs), but does not include training and other capacity-building
in surveillance, laboratory diagnosis, and control of viral pathogens such as Ebola Virus Disease, COVID-19
and Lassa Fever. With maturation of our training and research on malaria and NTDs, and an increased supply
of highly qualified mentors and trainees in Mali, we propose an increased emphasis on training on EIDs in
Mali and Guinea and mentoring by Malian, Guinean and US researchers. This training program will
provide a curriculum for training doctoral and master’s students in advanced field epidemiology and
laboratory practices, as well as non-degree certifications (professional skill enhancement) in
translational clinical research, public health emergency management and genomic surveillance of
emerging infectious pathogens, preparing Guinea and Mali to better handle potential future
epidemics. This program is a south-south collaboration effort between Guinea and Mali, supported by Johns
Hopkins School of Public Health (JHSPH), to have researchers from both sides collaborate more closely on
these cross-border diseases for more coordinated and efficient public health responses. The training program
will support six doctoral students and 15 master’s students. Dissertation of Doctoral and Master thesis
research will include research questions related or applicable to Ebola and other EIDs. Supported students
will take courses from, and be mentored by, faculty from the University of Conakry, USTTB, and JHSPH.
Selected students will have the opportunity to take online courses at JHSPH that are not offered at the
University of Conakry or USTTB. The program will also provide faculty enrichment through training and
coursework for eight faculty members, which may include trainings or online coursework at JHSPH and
will provide laboratory training for five research scientists (students or faculty). Short courses will also be
offered twice per year, training 120 public health professionals and young scientists in topics related
to the control of EIDs. This support will greatly enhance capacity in Guinea and Mali to respond to and
control impending outbreaks of EIDs in their own countries, and in the West African region.

Public health relevance
Project Narrative The recent epidemics of Ebola in West Africa and the current COVID-19 pandemic highlight the need for a critical mass of well-trained scientists and health research professionals capable of studying and responding appropriately, and in timely manner, to emerging infectious diseases outbreaks. This training program offers high-level training in field and laboratory epidemiology, translational clinical research, public health emergency management and genomic characterization and surveillance of emerging infectious pathogens. This proposed project is a south-south collaborative research training program between the University of Bamako (USTTB) and the University of Conakry in Guinea, supported by Johns Hopkins University and NIAID. It will contribute to a more coordinated cross-border approach of public health preparedness and response to emerging infectious diseases epidemics.